Behavioral and physiological measurements of hearing in mouse models of Alzheimer's Disease

Project Summary
A link between hearing loss and dementia is well established from epidemiological studies; however, whether or
not there is a causal link between hearing loss and dementia is unclear. The primary goal of the proposed
research is to use Common Fund datasets to investigate common genetic mutations associated with hearing
dysfunction and cognitive deficits. The proposed research extends the scope of the parent grant which focuses
on characterizing the behavioral and physiological trajectory of hearing loss in three specific mouse models with
gene mutations that result in brain pathologies mimicking certain aspects of Alzheimer’s and related dementias
(ADRD) in humans. While these models are useful for investigating the potential contribution of specific
predetermined pathological trajectories in hearing dysfunction, they do not adequately recapitulate human
dementias, which may arise from a host of mechanisms and display varying cognitive-behavioral phenotypes.
Identification of genetic factors that predispose a person to both hearing dysfunction and dementia is critical for
developing more valid animal models and probing potential mechanisms to target with biomedical treatments.
We hypothesize that abnormal cognition will be more prevalent in KO mice with hearing dysfunction compared
to those without hearing dysfunction. Our research will address this knowledge gap through two Specific Aims
that use Common Fund data to investigate additional genotype-phenotype relationships between hearing
dysfunction and cognitive deficits: 1) Analyze correlations between hearing phenotypes and cognitive-emotional
behavioral phenotypes in data from the Knockout Mouse Phenotyping Program (KOMP2) to identify common
genetic mechanisms, and 2) Compare genes of interest identified in Aim 1 against publicly available data in the
Human BioMolecular Atlas Program (HuBMAP) and other publicly available data repositories to determine which
human tissues express these genes and which genes are known to be expressed in the peripheral and central
auditory systems. Additionally, we will quantify the co-occurrence of hearing dysfunction, cognitive deficits, and
anxiety, fear, or stress phenotypes. We will consider sex as a biological variable to determine if hearing
dysfunction with cognitive phenotypes are more prevalent in males or females in the KOMP2 dataset. This work
will inform future investigations linking the trajectory of hearing dysfunction with cognitive deficits, including
ADRD, and provide potential targets for future preclinical studies investigating novel therapeutic interventions.

Public health relevance
Project Narrative There is a significant gap in what we know about the causal link between hearing loss and Alzheimer’s Disease and related dementias. This study will use publicly available datasets to characterize the relationship between hearing dysfunction, other sensory dysfunction, and behavioral cognitive and emotional dysfunction in animal models to identify potential common genetic drivers of these phenotypes and provide new potential targets for therapies to prevent or ameliorate hearing loss and dementia.